INSULIN AS AN EFFECTOR OF STEROIDOGENESIS IN HUMAN FEMALE

To determine whether hyperinsulinemia may lead to hyperandrogenism. Study of the possible effects of acute hyperinsulinemia on steroidogenesis in normal human females.